DP21-001 Pregnancy Risk Assessment Monitoring System (PRAMS)

Component A: Core Surveillance – Pregnancy Risk Assessment Monitoring System
PD/PIs: Paulette Valliere, MPH; David Laflamme, PhD, MPH
New Hampshire Division of Public Health Services
Project Summary
The goal of the Pregnancy Risk Assessment Monitoring System (PRAMS) is to reduce infant
morbidity and mortality and to promote maternal health by informing maternal and child health
(MCH) programs and policies, and influencing maternal behaviors during pregnancy and early
infancy. The objectives of PRAMS are: (1) to implement state-specific population-based
surveillance on maternal attitudes, behaviors and experiences that occur prior to, during and after
pregnancy; (2) to collect population-based data of high scientific quality; (3) to conduct data
analyses to inform programmatic activities and public health practice; (4) to translate and
disseminate analytic results into usable information for public health action; and (5) to have
capacity to respond to post-disaster or pandemic surveillance needs that may arise by
implementing a PRAMS survey supplement or oversample.
The objectives will be accomplished by ongoing activities such as: collecting data otherwise
unavailable; describing maternal behaviors, attitudes, and experiences during pregnancy and
early infancy; influencing public health policy by working with policy makers to incorporate
findings into the decision-making process; and committing state staff and resources to develop
expertise in the skills required to conduct surveillance.
The PRAMS methodology includes drawing a sample of women from the state birth file; sending
mailed questionnaires (up to three) on a specific timeline; following up all non-responders with a
series of up to 15 telephone calls over 30 days by a trained interviewer.
These goals, objectives, and methodology are in accordance with the national PRAMS protocol.
New Hampshire (NH) PRAMS staff will follow PRAMS research methods in the conduct of this
surveillance project to produce high quality data. A statewide MCH needs assessment conducted
in 2020 identified seven new soon-to-be-released priority areas that are the focus of MCH efforts
to improve the health of women and babies in New Hampshire over the next five years. These
priorities include a range of needs such as decreasing the use and abuse of alcohol, tobacco and
other substances among pregnant women, improving access to needed healthcare services for all
MCH populations, improving access to mental health services for women in the perinatal period,
increasing the focus of Title V on the Social Determinants of Health and the resolution of
barriers impacting the health of the MCH population, and reducing unintentional injury in
children 0-21 years of age. The information from PRAMS will fill critical data gaps and inform
policies, systems, and programs that address these and other MCH priorities.

Public health relevance
Component A: Core Surveillance – Pregnancy Risk Assessment Monitoring System PD/PIs: Paulette Valliere, MPH; David Laflamme, PhD, MPH New Hampshire Division of Public Health Services Public Health Relevance Statement The public health relevance of PRAMS consists in the collection and analysis of data which is translated to explain and provide an understanding of maternal and child health needs, behaviors and outcomes. This is critical to the design and implementation of programs and policies to improve health. PRAMS data fill a crucial information gap and provide standardized data which can be compared to and aggregated with the data from other PRAMS projects across the United States.